Analyses of animal food or drug related illnesses and large-scale animal food/feed emergency events requiring surge capacity.

FDA CVM Vet-LIRN PROGRAM (U18) GRANT PROPOSAL FOR FOA # PAR-17-141 Abstract This grant proposal from the Ohio Department of Agriculture (ODA) is in response to Funding Opportunity Announcement (FOA) # PAR-17-141 from the Food and Drug Administration's (FDA) Center for Veterinary Medicine (CVM) Office of Research Veterinary Laboratory Investigation and Response Network (Vet-LIRN). The purpose of this proposal from ODA's Animal Disease Diagnostic Laboratory (ADDL) is to address the following three key project areas: 1. Participation in FDA/Vet-LIRN surveillance assignments and sample analysis in the event of animal food or drug-related illnesses or other large-scale animal food/drug emergency events requiring surge capacity testing of implicated diagnostic or animal food samples. 2. Providing analytical data using standardized methods, equipment platforms, and reporting methods; participation in proficiency testing and method training provided by the Vet-LIRN Program Office (VPO) at the Center for Veterinary Medicine; and implementation of standardized quality management systems for laboratories. 3. Participation in small-scale method development, method validation and/or matrix extension work as determined by the VPO. A successful implementation of the project outlined in the proposal is predicted for many reasons including the extensive experience of the ADDL's professional and technical staff. The qualifications of the technical and professional staff are presented. As part of the proposal, a detailed view of the laboratory facilities and quality system are provided. This grant proposal also addresses the CVM request for sample analysis commitment as well as the laboratory's ability and willingness to complete the proposed research in a timely manner. Several additional documents including the internal Proficiency Testing (PT) results (see Research Stragety), and certificate of AAVLD accreditation (appendix of Research Plan) are provided along with the

Public health relevance
FDA CVM Vet-LIRN PROGRAM (U18) GRANT PROPOSAL FOR FOA # PAR-17-141 Narrative This Vet-LIRN cooperative agreement enables the analyses of animal diagnostic samples and animal food/drug products in the event that laboratory investigations or surge capacity are needed by Vet-LIRN and the FDA for analyses related to microbiological or chemical contamination, either through intentional or unintentional means. Identifying new and rapid analytical techniques and providing well-equipped and staffed laboratory facilities increases the effectiveness of Federal, State, and local partnerships to coordinate food safety and defense resources and reduce the incidence of foodborne illness.